MATERNAL OBSTRUCTIVE SLEEP APNEA AS A RISK FACTOR FOR IUGR

To test the feasibility of a project employing a case-control approach to explore the effect of maternal obstructive sleep apnea (OSA) on intrauterine growth retardation (IUGR). It is hypothesized that the potential vasoconstriction and hypoxemia contributes to the probability of IUGR. Also, to explore whether pregnancy exacerbates OSA.